Impact of Airway Epithelium on Innate and Adaptive Immunity in the Lung

PROJECT SUMMARY RESEARCH PROJECT 2
Respiratory viruses, such as respiratory syncytial virus (RSV), are major triggers of asthma exacerbation in
children and adults. The overarching hypothesis of this project is that airway epithelial cells (AECs) coordinate
responses to respiratory virus infection and aeroallergens. Moreover, intrinsic differences between AECs of
asthmatic and healthy children change both innate and adaptive responses during infection and exposure to
allergens. We hypothesize that infection of AECs from asthmatic children with RSV or HRV, in
combination with allergen exposure, induces resident innate cells, including dendritic cells (DCs) and
innate lymphoid cells (ILCs), to trigger type-2 responses. We will test this idea using AECs isolated from
asthmatic and healthy children, grown at air/liquid interface (ALI) and infected with respiratory viruses in the
context of allergen challenge. We will examine the response of DCs and ILCs co-cultured with these AECs, and
their role in promoting type-2 inflammation through the following aims:
Aim 1. Test hypothesis that AECs control local DC maturation and function. Since AECs in
asthmatics may be “leaky” due to barrier defects, we will first determine whether more antigen is transferred by
asthmatic than healthy AECs to DCs using modified RSV strains. Then, we will test whether AECs from asthmatic
children differ in promoting DC differentiation and function, and how virus infection and allergen exposure impact
this interaction. Finally, we will assess the ability of DCs exposed to AECs from asthmatic children to drive CD4
T cell differentiation and proliferation in co-culture assays.
Aim 2. Test hypothesis that after allergen exposure and viral infections, asthmatic and healthy
AECs differentially impact lung ILC2 through lipid mediators and vasoactive intestinal peptide. We will
assess the role of AECs in regulating ILC2s, which are the most abundant ILCs in the lung. We expect to find
that AECs from asthmatic children enhance ILC2 function during viral infection and allergen challenge. In our
preliminary data, we found two distinct subsets of human lung ILC2s that differentially express receptors for
oxysterols, retinoic acid, and vasoactive intestinal peptide. Thus, we propose to define the impact of these lipidic
and neuropeptide mediators on the activation of different ILC2 populations.
Aim 3. Test hypothesis that ICOS+ ILCs regulate lung immune responses. We made the novel
observation that the lung contains an unusual subset of ICOS+ ILCs. These cells do not fit into the ILC1, ILC2,
ILC3 paradigm, express a marker of regulatory lymphocytes and are enriched in an immunosuppressive
environment associated. Thus, we hypothesize that these cells may have regulatory functions. To test this, we
propose to isolate lung ICOS+ ILCs and define their transcriptome profile ex vivo as well as their functional
capabilities in vitro, including cytokine and chemokine secretion. Moreover, we propose to test their
responsiveness to stimuli derived from ALI cultures exposed to HDM and/or viruses.